Cholinergic neuron degeneration after HI: New target for delayed therapy of neonatal HI to improve Learning and Memory Deficits

Hypoxic-ischemic (HI) encephalopathy (HIE), the most frequent cause of acquired brain injury in preterm and
term infants causeslife-long morbidity. As many as 1 million infants/year suffer HIE with therapeutic
hypothermia (TH) affording a strong survival benefit in those with access to TH. Erythropoietin is also proving
effective both alone and with TH. However, both therapies must be started early. Despite significant progress
in neonatal HI injury research, a therapy that is effective beyond the acute phase of the disease and is orally
bioavailable has been elusive. Most babies affected by HIE have no access NICU care, TH, Epo or any other
upcoming therapies within the necessary time frames. A delayed, easily administered therapy for HIE would
change the future for 1 million children each year. Long term follow-up of HIE patients reveals permanent
learning and memory deficits, lack of cognitive flexibility, and executive dysfunction. MRI studies of former
infants with neonatal brain injury reveals degeneration in the cholinergic basal forebrain (cBF), occurring with
learning and memory deficits and poor executive function. The cBF is essential for proper executive function,
cognitive flexibility, learning and memory, arousal, spatial learning, decision-making, modulation of cortical
activity and the default mode network. The cBF is an interesting and novel potential therapeutic target for
neonatal HI because we now show that neonatal HI precipitates cholinergic neuronal degeneration in the cBF
and striatum. These cholinergic neurons enter a degenerative state 1 month after HI in concert with forebrain
injury and prior to time at which we find poor cognitive flexibility in the neonatal HI model. Much is known
about degeneration of cholinergic neurons in adult neurodegenerative diseases. Importantly, cholinergic
neurons have an extended prodromal phase of degeneration prior to cell death that is amenable to therapy,
and a drug targeting cholinergic neurodegeneration is in adult human trials. LM11A-31 is an orally bioavailable
modulator of p75NTr function that suppresses its neurodegenerative properties and enhances its
neuroprotective actions specifically in the cBF. Based on current data, we hypothesize that initiating treatment
with LM11A-31 after neonatal HI will rescue or prevent degeneration of cholinergic neurons in the cBF and
prevent degeneration of cholinergic input to the cortex resulting in improved learning, memory, and cognition.
We address the hypothesis by using a high through-put behavioral touchscreen testing system, that detects
learning and memory deficits, to rapidly determine LM11A-31 efficacy. Our Aims are 1: To assess the effect of
LM11A-31 in the developing mouse brain and its effect on pathology of neonatal HI throughout the brain,
especially in the injured cBF, when given from 4 days to 10 weeks after neonatal HI.
And 2: Determine whether use of LM11A-31 from 4 days-10 weeks after HI improves visual discrimination
and reversal learning tested 3-6 months after HI and whether this correlates with rescue of the cBF.

Public health relevance
Project narrative The vast majority of the 1 million infants worldwide that suffer HI at birth do not and will not have access to the advanced NICU care that allows for rapid initiation of current therapies. Infants that survive with and without current state of the art care for neonatal HI, face serious learning and memory deficits that affect the rest of their life. With this proposal we will examine injury to parts of the brain not previously investigated and attempt to rescue these brain cells with a novel drug (LM11A-31) that can be given by mouth.